Improving Opioid Use Disorder Treatment Retention Outcomes Using Mindfulness in Childhood Trauma Survivors

ABSTRACT
This Mentored Patient-Oriented Research Career Development Award (K23) application seeks support for
research training to augment the candidate’s knowledge and skills in co-occurring childhood trauma and opioid
use disorder (OUD) in order to support her progress to become an independent investigator. During the award,
the candidate will develop and implement a research program related to technology-based mindfulness
interventions and use of biomarkers to improve engagement in medication treatment for opioid-use disorder
(MOUD) in those who have experienced childhood trauma. The central hypothesis is that changes in autonomic
function and inflammation mediate the relationship between childhood trauma and poor treatment retention in
MOUD, and that mobile mindfulness training (mMT) is feasible in this population with potential benefits to
emotional, inflammatory, and autonomic function. This proposal includes training activities to ensure Dr.
Meadows achieves the following career goals: 1) Training in the discovery, interpretation, and assessment of
potential biomarkers to assess the link between childhood trauma and outcomes, 2) Advanced training in the
design and implementation of clinical interventions, and 3) Training in the analysis and interpretation of data.
The mentorship team includes experts in the following areas of research: substance use disorders (Drs. Rush
and Martin), intervention development (Dr. Rush), and advisors with expertise in the use of mobile mindfulness
training for substance use disorder (Dr. Reynolds), inflammatory biomarker evaluation (Dr. Moylan), heart rate
variability (Dr. Minassian), trauma treatment (Dr. Sprang), and advanced statistical modeling (Dr. McLouth). Dr.
Meadows will apply the skills from the training to test the three specific aims: 1) Demonstrate baseline differences
in autonomic function, inflammation, and treatment engagement between those with a history of childhood
trauma and those without childhood trauma or post-traumatic stress disorder enrolled in MOU, 2) Implement and
evaluate mMT in childhood trauma-exposed individuals enrolled in MOUD in order to a) demonstrate feasibility
and acceptability and b) estimate effect sizes for improvements in emotional health, autonomic function, and
inflammation, and 3) Assess whether mMT improves treatment engagement and retention in MOUD. The
proposed research is innovative because it will provide insight into the relationship between potential biomarkers
and treatment engagement in MOUD. It is also highly significant because it focuses on a mobile intervention that
can be readily adapted as an adjunct to existing treatment programs to improve outcomes. The research, training
plan, mentorship, and institutional support will facilitate Dr. Meadows’s transition to becoming an independent
physician-scientist to better serve the needs of individuals with co-occurring childhood trauma exposure and
substance use who are at the highest risk of treatment dropout and poor outcomes.

Public health relevance
PROJECT NARRATIVE Childhood trauma survivors have higher rates of treatment dropout during medication treatment for opioid use disorder (MOUD), with those who leave treatment early being at extremely high risk for recurrence of opioid use disorder (OUD). Autonomic nervous system dysregulation and inflammation may mediate risk for dropout and/or return to use during MOUD in childhood trauma survivors, but mindfulness interventions may normalize psychological and physiological changes attributable to early childhood stress. The proposed project will implement a research program to elucidate the interplay of biological and psychological risk and protective factors associated with treatment retention in individuals in MOUD to guide the development of clinical interventions, improve treatment adherence, and reduce the risks of OUD.